Protein-based Self-assembly and Disassembly of Nanostructures

PROJECT SUMMARY / ABSTRACT
Our research program is focused on developing robust platforms that enable protein-based biologics as
therapeutics for intracellular targets. Biologics offer distinct advantages over small molecule drugs, because
of their high specificity, including against targets that are considered undruggable with small molecules.
However, large size and hydrophilic nature of proteins present the formidable challenge of transporting them
to intracellular locations. Protein-based therapeutics have been, thus, largely limited to extracellular targets.
Recognizing this gap, we have focused on developing a platform with the combination of characteristics,
critical for transporting proteins inside the cells. Accordingly, we arrived at a new protein-encapsulating
nanogel system that effectively and tracelessly delivers the proteins inside the cells in its functional form.
Over the next five years, we seek to build on these accomplishments to explore new scientific directions. We
will create a new antibody-directed antibody conjugates (ADACs) platform with the goal of engaging currently
undruggable intracellular targets in specific cells. ADACs contain two distinct antibodies – one for targeting
extracellular epitopes for cellular specificity and another for engaging a specific intracellular target. We
leverage the combined capabilities of the protein-polymer self-assembly to generate nanogels with the
bioorthogonal chemistries developed for decorating the nanogel surfaces with antibodies, to create ADACs
with tunable physiochemical characteristics. We will investigate the potential for ADACs in targeted protein
degradation (TPD) of model intracellular targets that are considered undruggable, because of a single
missense mutation or single site post-translational modification. In this context, we will also fully test the
potential of the TRIM21 E3 ligase pathway for proteasomal TPD using antibodies and compare its efficacy
with the more classical inhibition pathway in eliciting downstream responses. Concurrently, we will also
develop new strategies for increasing the efficacy and specificity of antibody-based biologics using the ADACs
platform. Endosomal escape has been identified as the major bottleneck in the efficacy of intracellular
biologics. We propose two new, mechanistically distinct strategies for functionalizing nanogel surfaces that
promote endosomal escape. Similarly, to substantially enhance cellular specificities of therapeutics, we
propose a high-risk, high-payoff strategy for in-cell assembly of antibody-like molecules using Boolean logic
based convergence.
We have chosen the components of our approaches to be independent, such that each of our scientific goals
independently inform new strategies for solving critical and unsolved issues in the field of intracellular
biologics. Simultaneously, these goals are also designed to be convergent such that when put together, the
impact of our overall approach will be exponentially higher. Collectively, our program will inform and develop
strategies for enabling biologics as the next generation therapeutics for intracellular targets.

Public health relevance
PROJECT NARRATIVE This research program is focused on developing design guidelines for protein-polymer self-assembly to enable intracellular biologics. Our studies towards this goal focus on fundamentally understanding the factors that underlie cell-specific transport of the nanoassemblies, endosomal escape, targeted protein degradation, and strategies for in-cell assembly of biologics.